Community Engagement Core

PROJECT SUMMARY: Community Engagement Core
Communities living near contaminated waterways and using old school buildings are concerned about the
health impacts of airborne polychlorinated biphenyls (PCBs), a class of Superfund chemicals, on their
communities. Moreover, current PCB remediation practices require substantial resources and are highly
disruptive, for example, dredging contaminated sediments in waterways or demolishing school buildings. There
is a critical need to address community needs for information and accessible, acceptable, and effective tools
for PCB remediation. The long-term goal of the Community Engagement Core (CEC) is to reduce the overall
amount, toxicity, and health disparities from airborne PCBs through rigorous scientific research that is co-
created with affected communities and that develops innovative prevention and intervention strategies. Our
overall objective is to leverage ISRP and community resources in collaborative research with the Portland
Harbor Community Coalition and Vermont school officials that informs remediation decisions in these
communities. Our rationale is that partnership with communities of place and practice impacted by PCBs
strengthens scientific rigor and contributes relevant tools for community action. Our objective will be addressed
in three aims: (1) Facilitate community-engaged research between the ISRP, PHCC, and other interested
parties in Portland, Oregon to address community concerns about sources and impacts of airborne PCBs; (2)
Integrate community and ISRP expertise to support school officials and staff in Vermont in making informed
decisions about PCB remediation interventions; and (3) Embed community engagement best practices across
the ISRP to mobilize whole-Center involvement with ISRP community partners and increase overall volume of
ISRP community engaged research. The goal of the first aim is to help identify intervention opportunities that
most effectively reduce the amount and toxicity of airborne PCBs in the Portland Harbor area. For the second
aim, the CEC will lead a Center-wide effort to develop a PCB Decision Support Toolkit to inform targeted
material remediation in schools. For the third aim, in collaboration with community partners and all projects and
cores, the CEC will provide regular learning opportunities and create and deploy a playbook of best practices
for community engagement about airborne PCBs. The proposed work is innovative because it interweaves
community, regulatory, and scientific knowledge about PCBs in a rich social science-environmental health
research framework; provides novel evidence-informed decision support for PCB remediation activities to our
current partners; and increases the scope and scale of community engaged PCB research. These
contributions are significant because robust, effective, efficient, and mutually beneficial community
engagement will enhance the quality, relevance, and accessibility of PCB science and evidence-informed tools
will inform and catalyze remediation activity. Ultimately, such knowledge and tools have the potential to reduce
hazardous PCB exposure and related health consequences and disparities.

Public health relevance
PROJECT NARRATIVE: Community Engagement Core The proposed CEC activities are relevant to public health because they interweave community, scientific, and regulatory knowledge to address community concerns about PCBs, a class of Superfund chemicals, near contaminated Superfund sites and in school buildings. Partnering with impacted communities in the research process will introduce vital community knowledge that will ensure relevance to our community partners in Portland and Vermont, enhance study richness, and boost translation to impact Superfund end-users more broadly. The work of the CEC is relevant to the Superfund Research Program's fourth mandate because it will inform remediation of the Portland Harbor Superfund site and will identify and communicate efficient and effective solutions to decrease the amount and toxicity of airborne PCBs in Vermont schools.